Population Biology of African Malaria Vectors and Parasites

Population Biology of African Malaria Vectors and Parasites
Malaria is the most fatal vector-borne disease in Africa. At present, the first-line
intervention tools are insecticide-treated nets and indoor residual spray that target
indoor-biting mosquitoes. However, the spread of insecticide resistance and increasing
outdoor biting behaviors of the malaria vectors has significantly hindered the
effectiveness of these tools, resulting slow progress of malaria control in the past
several years across Africa. In addition, the African continent has been experiencing
very rapid environmental changes such as urbanization, deforestation, dam
construction, irrigation and the resulting agricultural practice shift in the past two
decades. On top of the vector behavioral change and insecticide resistance
development, rapid environmental changes in the African continent have added
additional challenges in malaria control. Addressing these challenges in malaria control
requires knowledge on the impact of environmental modification on vector biology and
epidemiology, and requires optimization of the vector control methods that are adaptive
to the rapidly changing vector ecology and malaria epidemiology. Recent advancements
in molecular biology, genomics, bioinformatics and ecological modeling, provide exciting
opportunities for developing new malaria vector control tools and application strategies.
Unfortunately, a large number of scientists from malaria-endemic countries have not
been able to leverage these new technologies extensively in their research. The specific
scientific objectives of this competing renewal application focus on mechanistic studies
on the impact of environmental modifications on malaria vector biology, epidemiology,
and development and evaluation of new malaria vector control tools and application
strategies. The overarching goal of this program is to advance the career development
of promising young scientists from sub-Saharan African countries and assist them
address the new challenges in malaria vector control in their regions. We propose to
accomplish this goal by training four postdoctoral fellows and eight Ph.D. students from
malaria-endemic Africa, and through workshops and “training the trainers” sessions to
broaden the impact of this program. In addition to obtaining research experience in
molecular biology, bioinformatics, vector ecology and epidemiology, the program will
offer a core training curriculum that focuses on biostatistics, bioinformatics, modeling,
scientific writing and responsible conduct of research. The superb infrastructure and
capacity at the international training sites in Kenya and Ethiopia and at the University of
California at Irvine are ideal for the proposed training. This training program will
contribute significantly to malaria research capacity building in Africa and career
development of African scientists by bridging laboratory and field research experience in
vector biology and malaria epidemiology, by equipping them with new technologies, by
providing opportunities for them to develop valuable Africa-wide and international
linkages, and empowering them to build and develop independent research capacity
and projects.

Public health relevance
Public Health Relevance: Malaria is a major public health problem, particularly in sub- Saharan Africa. Advancements in molecular biology, bioinformatics, modeling and other disciplines provide exciting opportunities to develop new vector control tools. The vast majority of scientists from malaria-endemic Africa have not been able to use these new technologies to their maximum potential. Training next generation scientists to enable them to effectively use the new technologies and enhancing the malaria research capacity from malaria-endemic Africa will greatly facilitate the malaria control efforts in Africa.